Core-006

The Network Capacity Core helps the Center for Clinical and Translational Science achieve its vision of improving human health by providing a Liaison to Trial Innovation Centers (LTIC) and a Liaison to Recruitment Innovation Centers (LRIC). The specific aims of the LTIC are: 1) To enhance innovation, access and quality to speed protocol implementation and study completion evaluated through objective metrics; 2) To use our Local Trial Innovation Unit (LTIU) to streamline and facilitate study start-up and implementation; 3) To use clinical research staff experienced in IRB activities, contracting, budgeting for clinical studies, coordination and project management to support network wide studies and assure timely study implementation and completion; 4) To use the LTIU to accelerate IRB, budgeting, contracting and other startup timelines through parallel rather than sequential work steps, and through process re-engineering; 5) To use the LTIU to track study metrics related to study start-up, implementation and close-out, collaborating with the CTSA network-wide initiative that is developing common metrics for the CTSA program; 6) To use the LTIU as liaison to the CTSA Trial Innovation Centers (TICs), including implementing IRB reliance and pre-negotiated master subcontracts; 7) To use the LTIU to streamline the implementation of clinical research; 8) To use the LTIU to coordinate between reliance on a central IRB and the other research oversight tasks carried out at the institution, such as radiation safety approval, or conflict of interest reporting and management. 9) To engage work locally to aid efficient trial implementation, and are willing to engage with the TICs. The specific aims of the LRIC are: 1) To develop a unit dedicated to supporting the recruitment of trial participants; 2) To populate and support patient/participant databases to facilitate identification of participants for trial recruitment; 3) To incorporate data expertise to facilitate ready identification of potential research participants; 4) To integrate staff with expertise in clinical research, patient engagement, communications, cultural competency and ethics so that potential research participants are notified in an ethical and effective manner; 5) To interact with the CTSA Network Recruitment Innovation Centers and to incorporate best practices as a network member; 6) To develop and support the capacity to identify patients/volunteers from databases at the CTSA who are potentially eligible for RIC network trials, and share de-identified aggregate information with the RIC; 7) To assure human subject protections and participants privacy; and 8) To recruit participants to network trials in accordance with applicable HIPAA and consent documents; 9) To utilize an effective outreach model; 10) To support capacity to interact effectively with the RICs; 11) To provide assistance to investigators in contacting participants and harmonize policies with effective recruitment best practices; 12) To track monthly enrollment into clinical trials. To achieve these goals, expert teams will streamline trial development and implementation by new methods and will adopt and implement recommendations of TICs and RICs at the network level.